Total Brain Diagnostics (TBD): Examining the Impact of Fluid and Neuroimaging Biomarkers on Outcomes after TBI

Project Summary
Traumatic brain injury (TBI) has been termed the “signature injury” of the recent military conflicts
in Iraq, with incidence estimated between 9-28%. While the vast majority of TBIs are mild, long-
term effects can persist years post-injury. TBI can impact psychological health, physical health,
functioning, and quality of life, but predicting outcome post-injury is challenging. Large sample
sizes are necessary to accurately characterize heterogeneity in outcome, and two on-going
longitudinal studies have collected in-depth data with the goal of improving Service Member and
Veteran (SMV) health. Long-term Impact of Military-relevant Brain Injury Consortium (LIMBIC)
and Translational Research Center for TBI and Stress Disorders (TRACTS) collectively have
gathered information on thousands of SMVs around the United States, and combining these
datasets will give us unprecedented power to examine factors that influence outcome post-
injury. This Proof of Concept (POC) project will demonstrate the feasibility of combining these
massive samples and will show the power of large datasets. Together, TRACTS and LIMBIC
have information on TBI severity, physiologic functioning, fluid, and imaging biomarkers,
behavioral factors, functional outcomes, and mental health outcomes on approximately 3,500
individuals, and our team has significant experience in collating and organizing large amounts of
data and applying harmonization methods to imaging, fluid biomarker, and clinical endpoint
data. With the expertise of our project team, we will pool and harmonize data for integrated
analyses. Combining and harmonizing data from different sources has many challenges, but the
project team has extensive, interdisciplinary expertise, particularly in the area of big data
analytics. Neuropsychological data will be combined by domain. Crosswalks and common
analytical methods will be created for both multimodal magnetic resonance imaging data (MRI)
and fluid biomarker data. MRI data will be harmonized using ComBat-GAM to minimize site
effects. Fluid biomarkers will be combined utilizing harmonization methods to integrate multi-
omic markers using newer methods including deep learning (DL) algorithms. Using the
biomarker data as independent variables and the cognitive and function data as dependent
variables, risk factors associated with brain disorders and recovery will be identified. Given
large, rich datasets, machine learning approaches can help outline symptom profiles, but careful
curation of datasets is critical to ensuring validity. Beyond the massive dataset generated by this
POC project, by creating and validating methods for combining multi-site data, a critical
deliverable will be the infrastructure for future cross-study analyses. The end goal of this project
is to leverage the vast amount of information available regarding TBI and SMV health to identify
generalizable biomarkers of outcome that can inform patient-tailored care and thus decrease
TBI-related morbidity.

Public health relevance
This proposed proof of concept (POC) project seeks to consolidate and harmonize neuroimaging and fluid biomarker data from two large, prospective, longitudinal studies in Service Members and Veterans (SMVs). In concert with related POC proposals, we will integrate this data into a unified dataset, and create infrastructure and validate methodology which will be later applied to additional datasets. This work will allow examination of the use of biomarkers in identifying factors that can improve diagnosis, prognosis, and response to treatment in order to improve total brain health in Veterans. This line of research will create the platform essential to personalize the care provided to SMVs by leveraging multiple levels of data in an integrative manner, thereby allowing for a better understanding of individual variations that shape recovery from TBI and associated comorbidities, and lead to the development and maintenance of chronic symptoms. This allows us to both prevent risk, and to provide novel interventions based on improved understanding of integrative mechanisms.